The genome-wide function of supercoiling and alternative DNA conformations

First , to establish that our hypothesis that transcriptionally generated DNA supercoiling regulates the activity of particular elements, we prepared a model system comprised of an EBV-based episome where the FUSE element was sandwiched between divergent metallothionein promoters. By adding zinc to defined levels we could adjust the level of ongoing transcription and control the forces propagated onto FUSE. Upon exceeding a key threshold, the FUSE element would become single-stranded, recruit the specific single stranded DNA binding protein FBP, and reprogram the output of the metallothionein promoters. Using Cre-recomb.inase to excise precisely defined DNA circles, allowed us to monitor directly the accompanying changes in DNA topology validating this novel mechanism as potentially general principle to confer precise control on activated promoters. We are now developing experimental and analytical approaches to map the level and distribution of supercoiling forces on a genome-wide basis. to accomplish this we are exploiting the known preference for psoralen to intercalate into negatively supercoiled DNA. Because psoralen readily penetrates living cells and can be cross-linked to DNA by a pulse of UV light, by comparing the relative hybridization of cross-linked to uncross-linked DNA to high density genomic tiling arrays, we can map the genome-wide distribution of psoralen. By including proper controls to account for ongoing transcription, chromatin structure, and by eliminating the influence of replication (by using properly synchronized cells), we can infer the distribution of supercoils. Because high levels of supercoiling promotes the formation of non-B DNA structures, we have also devised a method to map the distribution of non-B DNA across the genome. Virtually any of the non-B DNA structures formed in vitro result in the exposure of DNA bases to the local solvent (at least the the junctions between B and non-B DNA), potassium permanganate can be used as a chemical probe of unpaired bases. Because permanganate rapidly permeates cells, folowing a short exposure to this chemical, when DNA is extracted the permaganate oxidized pyrmidines in stabilize foci of non-B DNA and preserve sensitivity to cleavage by single strand specific endonucleases. Following cleavage with such endonucleases, these ends can be marked, and recovered and analyzed by hybridization to microarrays or by sequencing. Application of this approach reveals enrichment for permanganate sensitive sites in sequences computationally predicted to 1)be sensitive to supercoil induced duplex destabilization (SIDD); 2) to be Z-DNA (left handed double helix; or 3) to form G-quadraplex structures.